What is the human antibody response to measles virus vaccination?

PROJECT SUMMARY/ABSTRACT
Vaccines are the greatest bang for our public health buck, yet vaccine development is still sometimes hit or miss.
Recent efforts with SARS-CoV-2 demonstrated that acceleration of vaccine programs is possible, especially
when supported by prior studies characterizing successful immune responses against related prototype
pathogens. The measles virus vaccination campaign is a global success story; the live-attenuated vaccine
developed in the 1960’s still elicits highly protective antibodies to strains circulating today. Yet Measles outbreaks
persist due to obstacles in vaccination programs such as global health inequities, vaccine hesitancy, extreme
weather events related to climate change, and the SARS-CoV-2 pandemic. Furthermore, a growing population
with compromised immune systems cannot receive live-attenuated viral vaccines. Thus, the threat of measles
remains (there are still approximately 9-10 million cases annually), and innovative solutions will be needed to
achieve global measles eradication. However, very little is known about the human antibody response to measles
infection or vaccination beyond neutralizing antibody titers. Importantly, there are no structures of any antibodies
in complex with any measles virus antigens. As a result, we do not know which sites on measles virus are
immunodominant and protective. Much of this fundamental knowledge is lacking largely because measles was
effectively eradicated from developed nations before needed scientific tools had been developed. In this work,
we will use state-of-the-art tools to directly visualize the structure of human antibodies from vaccinee polyclonal
sera bound to measles surface glycoproteins to understand which antigenic sites dominate in the human
vaccinee response. We will also use microfluidics and rapid microscale multiplexed competition analyses to
rapidly discover and analyze individual human monoclonal antibodies against measles virus for the first time.
This work will reveal what components of the human immune response to this prototype paramyxovirus lead to
vaccine-mediated protection, and will help guide development of modern vaccines for the immunocompromised
and other vaccines against paramyxoviruses yet to emerge.

Public health relevance
PROJECT NARRATIVE This study will use state of the art tools to directly visualize and functionally analyze the human polyclonal and monoclonal antibody responses to measles virus vaccination for the first time. The information learned will explain how this successful vaccine works and will provide direction for development of next-generation vaccines and novel therapeutics targeting measles and other viruses in its broad paramyxovirus family.